Project 3: Negative regulation of type I interferons during bacterial infection

Project Summary/Abstract (Project 3, Vance)
Intracellular bacterial pathogens remain a major cause of human mortality and morbidity. By working
collaboratively with other P01 Projects, we focus in Project 3 on the role of type I interferons (IFNs) in the
innate immune response to three intracellular bacterial pathogens: Listeria monocytogenes, Mycobacterium
tuberculosis, and Legionella pneumophila. As we and others have shown previously, all three pathogens
induce the expression of type I IFNs via the STING pathway. However, while type I IFNs are generally
accepted to play a crucial role in orchestrating anti-viral immunity, the roles of type I IFNs in the responses
to bacteria are complex. Indeed, our work and that of other laboratories has shown that type I IFNs tend to
exacerbate infection by bacterial pathogens, including M. tuberculosis, L. pneumophila and L.
monocytogenes. Our preliminary data suggest that type I IFN-dependent induction of the interleukin-1
receptor antagonist (IL-1Ra) is an important mechanism by which type I IFNs exacerbate bacterial
infections. Our preliminary data also suggest the existence of regulatory pathways to prevent the adverse
induction of type I IFNs during bacterial infections. We identify SP140 and MORC3 as two novel negative
regulators of type I IFN expression. We propose three Aims to explain why type I IFNs hinder anti-bacterial
immunity and to explain how interferons are normally properly regulated during bacterial infections, in both
mice and humans. In Aim 1, we test the hypothesis that type I IFNs antagonize anti-bacterial immunity via
induction of IL-1 receptor antagonist, and determine the underlying mechanism. In Aim 2, we dissect the
mechanism by which SP140 negatively regulates type I IFN transcription during bacterial infections. In Aim
3, we identify and characterize MORC3 as a novel negative regulator of type I IFN in human cells, and
determine its function during bacterial infection.

Public health relevance
Project Narrative (Project 3, Vance) Intracellular bacterial pathogens cause significant mortality and morbidity worldwide. Here we propose to determine how innate immunity mediates resistance or susceptibility to three intracellular bacterial pathogens (Listeria monocytogenes, Legionella pneumophila, and Mycobacterium tuberculosis) with a particular focus on the role of type I interferons. We expect our work to lay a foundation for the rational therapeutic intervention in these infections.